Direct and Quantitative Proteomic Approaches in Xenopus

DESCRIPTION (provided by applicant): ABSTRACT The goal of this proposal is to develop and optimize the technologies and reagents for use of directed and quantitative proteomic approaches in Xenopus. Specifically, we propose a series of feasibility studies based on three proteins, the T-box transcription factors TBX5, the zinc finger transcription factor CASZ1, and the non-receptor protein phosphatase SHP2. We have focused on these proteins based on their evolutionary conservation in sequence, expression, and function, their cellular localization, and the observation that these proteins are causative, or have association with human disease states: patients with Holt-Oram syndrome (HOS), a disease which also affects the heart and limbs, is associated with mis-sense mutations in Tbx5, genome wide association studies have implied a role for Casz1 in hypertension and high blood pressure, and patients with Noonan syndrome, a disease that also affects heart and limb development, frequently is associated with mis-sense mutations in Shp-2. Despite the crucial role for TBX5, CASZ1 and SHP-2 in development and human disease, the molecular mechanisms by which these proteins act in vivo remains to be established. To address these issues and to establish a set of general technologies for the use of directed proteomics approaches in Xenopus we propose to 1) establish a binary transgenic system in Xenopus for the isolation of protein and protein-DNA complexes and 2) establish the technologies, reagents and protocols for directed and quantitative proteomic approaches in Xenopus.

Public health relevance
PUBLIC HEALTH RELEVANCE: PROJECT NARRATIVE This proposal is an integrative approach to develop and optimize the technologies and reagents for directed and quantitative proteomic approaches in the model system Xenopus and thus, advance its utility as a model system to study human disease. Specifically, we propose a series of proteomic feasibility studies to be performed on two proteins the T-box transcription factor TBX5, the gene mutated in the congenital heart disease, Holt Oram syndrome, the transcription factor CASTOR (CASZ1) a gene linked to hypertension and high blood pressure and the non- receptor protein phosphatase SHP-2, the gene mutated in Noonan syndrome, acute myelogenous leukemia, acute lymphoblastic leukemia, juvenile myelomonocytic leukemia, and LEOPARD's syndrome. __SpecificAimsTextDelimiter__ SPECIFIC AIMS SUMMARY: The goal of this proposal is to develop and optimize the technologies and reagents for directed and quantitative proteomic approaches in Xenopus. Specifically, we propose a series of feasibility studies to be performed on three proteins, the non-receptor protein phosphatase SHP-2, the T-box transcription factor TBX5, and the novel para-zinc finger transcription factor Castor (CASZ1). We have focused on these proteins based on their evolutionary conservation in sequence, expression, and function, their cellular localization, and the observation that these three proteins are associated with human disease states: Holt-Oram syndrome (HOS), a disease that affects the heart and limbs, is associated with mis-sense mutations in Tbx5, genome wide association studies have implied a role for CASZ1 in hypertension and high blood pressure, and Noonan syndrome, a disease that like HOS affects heart and limb development, is frequently associated with mis-sense mutations in Shp-2. Despite the crucial role for TBX5, CASZ1, and SHP-2 in development and human disease, the molecular mechanisms by which these proteins act in vivo remain to be established. To address these issues and to establish a set of general technologies for the use of directed proteomics approaches in Xenopus, we propose to: Aim 1. Establish a binary transgenic system in Xenopus for the isolation of protein complexes. We will develop a general binary transgenic-based approach in Xenopus using the Avi-tag/BirA system. This approach offers the unique advantage of combining the minimal invasiveness of a small peptide tag with the affinity and strength of the biotin-streptavidin attachment, a high affinity interaction that greatly exceeds the specificity of any antibody. Thus, this system offers the further advantage that it does not require a high-specificity, high-affinity protein-specific antibody for protein complex isolation. Therefore, this set of technologies will allow for identification and purification of potentially any protein complex from Xenopus. We will demonstrate the use of this system through the immunoprecipitation (IP) of TBX5, CASZ1 and SHP-2 protein complexes from Xenopus embryos. Aim 2. Establish the technologies, reagents, and protocols for targeted quantitative proteomic approaches in Xenopus. Xenopus offers a unique model system for identification and characterization of protein complexes in vivo. However, use of these approaches has been limited due to lack of optimized mass spectrometry-based protocols and workflows for analysis of early-stage tissues and embryos. To address these issues, we will develop and optimize reagents, procedures, and resources for use of liquid chromatography- tandem mass spectrometry (LC-MS/MS) for identification of components of protein complexes from Xenopus embryos and embryonic tissues, using as a test case TBX5, CASZ1 and SHP-2 complexes. Quantitative mass spectrometry will be used to examine changes in protein complex composition and alterations in SHP-2, TBX5 and CASZ1 post-translational modifications (PTMs) as a function of tissue specificity (i.e. SHP-2, TBX5) or time (TBX5, CASZ1 and SHP-2, heart early tadpole verses late tadpole verses adult). Collectively, these experiments will allow us to establish procedures for label-free quantitative proteomics in Xenopus, as well as generate and curate a general protein database for the community for Xenopus laevis and Xenopus tropicalis. The critical importance of this proposal will be its broad impact on the Xenopus and scientific community at large. Specifically: 1) This proposal will establish methodologies for the purification of proteins from Xenopus through optimization of buffers, protocols, and a generalized LC-MS/MS workflow. Thus, technologies will be developed and distributed to the community for a broad range of future applications. 2) The generation of Xenopus laevis (X. laevis) and Xenopus tropicalis. (X. tropicalis) transgenic lines put forth in this proposal will be valuable not only for proteomics studies, but also for other broad-based applications. For example, Avi-tag lines can be used for isolation of protein-DNA complexes for chromatin immunoprecipitation (ChIP)-seq, and the BirA line, in conjunction with an Avi-tag line, can be used to visualize almost any protein. Moreover, the generation of BirA constructs and transgenic animals will significantly reduce the cost of these types of experiments in any PI's lab. This is particularly true in Xenopus, where it is possible to inject BirA mRNA or use sperm or eggs derived X. laevis or X tropicalis BirA transgenic lines. The cost savings is two-fold: a) these approaches will not require the purchase of the BirA enzyme-usually the cost-limiting step to these experiments, and b) these technologies by-pass the need to purchase large quantities of a protein specific antibody. These are just a few examples of how the animals generated through this aim can be utilized. Collectively, since these animals will be made freely available to the Xenopus community and deposited in the Xenopus National Stock Center, the animals will represent an important community resource. 3) The generation and curation of a Xenopus protein database will further allow non- proteomic based labs the opportunity to undertake proteomic-based studies without the need to generate their own databases. This is of particular benefit to those PIs wishing to perform similar studies in collaboration with a proteomic core facility or a non-Xenopus based proteomic collaborator. 4) Finally, since each experiment generates protein sequences from 100-2500 proteins, Aim 2 will also have the indirect effect of facilitating the annotation of the X.tropicalis, and more crucially, the X. laevis genome. Thus, collectively, we believe our proposal will have broad impact on the Xenopus and general scientific community.